INFRASURF VS EXOSURF PROPHYLAXSIS TREATMENT OF NEONATAL RESPIRATORY DISTRESS

To compare effect of two different exogenous surfactants on neonatal mortality; compare effect of two different exogenous surfactants on the incidence and severity of acute RDS, air leak complications of RDS, and pulmonary hemorrhage; to compare the effect of two different exogenous surfactants on the incidence and severity of chronic lung disease and compare the effect of two different exogenous surfactants on the incidence of other RDS morbidities.